Guideline-directed management and therapy (GDMT) for the prevention of postpartum cardiac dysfunction in preeclamptic African American women

Project Summary/Abstract
African American women are 60% more likely to have postpartum hypertension and are nearly three times
more likely to die from preeclampsia than white women. Both during pregnancy and overall, hypertension in
African American women is more severe and presents earlier in life. In addition, compared to other ethnic-
racial groups, African American women have higher mortality rates from hypertension-related end-organ
damage like heart failure and stroke. Currently, however, no proven interventions exist to prevent or mitigate
the development of hypertensive heart disease during the postpartum period.
Using a randomized mechanistic clinical trial of guideline-directed medical therapy for postpartum African
American women with preeclampsia, we will advance knowledge of cardiac dysfunction in preeclampsia and its
possible treatments. We pursue a specific aim to answer these questions. AIM 1 is a randomized trial to test
whether guideline-directed medical therapy improves cardiac function and decreases blood pressure in
postpartum African American women with preeclampsia. This project innovates methodologically to
dramatically advance our understanding of a significant cause of morbidity and mortality in African American
women.

Public health relevance
Project Narrative African American women are 60% more likely to have postpartum hypertension and are nearly three times more likely to die from preeclampsia than white women. Both during pregnancy and overall, hypertension in African American women is more severe and presents earlier in life. Our interdisciplinary research team will conduct a randomized controlled trial to test whether goal-directed management and therapy (GDMT) improves cardiac function while exploring how this cardiac dysfunction occurs. This study will also allow us to learn more about how the heart malfunctions after preeclampsia and how best to support it.